Effect of Brain Lymphatic Activation on Alzheimer's Disease Progression

PROJECT SUMMARY
Failure of brain waste clearance by the cerebrospinal fluid outflow has been associated with various neurological
diseases. Disruption of the meningeal lymphatics in Alzheimer's disease (AD) mouse models leads to amyloid-
β deposition in the meninges and aggravates parenchymal Aβ accumulation. The 5xFAD mouse model displays
impaired lymphatic function and contractility and significantly delayed brain fluid outflow. These results suggest
that meningeal lymphatics profoundly contribute to brain fluid homeostasis and that optimal brain fluid drainage
is critical for maintaining brain health and function. Consistently, our preliminary studies demonstrate that
activation of the brain lymphatics through a mechanosensor Piezo1 expedited the brain fluid outflow in two
mouse models with abnormal brain fluid accumulation. Together, we hypothesize that enhancing the brain
lymphatic drainage would offer therapeutic benefits to AD. To address this hypothesis, we propose to stimulate
the brain lymphatic drainage by genetic (Aim1) and chemical (Aim2) activations of Piezo1, followed by evaluating
their effects on the initiation and progression of AD. Together, the outcome of this work will not only identify
Piezo1 as a novel target for AD, but also provide a conceptual foundation for enhancing the brain lymphatic
drainage as a novel therapeutic approach against various neurological diseases.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a degenerative brain disease and the most common form of dementia. The disease is associated with impaired brain waste clearance due to lymphatic dysfunction. The proposal aims to evaluate the potential therapeutic benefits of re-activating brain lymphatic function on Alzheimer’s disease. If brain lymphatic activation could suppress Alzheimer’s disease, the outcome of this study will help develop a novel therapeutic agent against Alzheimer’s disease.